BRAIN MEASURES OF A^ METABOLIC MOLECULES AND CONNECTIVITY

The aggregation of normally soluble amyloid-β (Aβ) into toxic forms, such as amyloid plaques and oligomers, first begins approximately 10-15 years prior to the onset of cognitive decline associated with Alzheimer's disease (AD). In humans, there is a unique susceptibility of specific brain regions to Aβ deposition. These regions markedly overlap with the brain's default mode network (DMN). The DMN is a series of brain regions that display high functional connectivity (fc) and neuronal activity while an individual is not engaged in a goal directed task. These regions also demonstrate increased glycolysis, which for the purposes of this PPG refers to glucose uptake in excess of that used for oxidative phosphorylation despite sufficient oxygen to completely metabolize glucose to carbon dioxide and water. It is unclear whether increased glucose/insulin levels can alter glycolysis within the DMN and whether this influences Aβ levels, synaptic function, or exacerbates AD pathology. This is of interest given the increased risk of AD in patients with diabetes. To understand the relationship between brain glucose/insulin utilization, Aβ deposition, behavior, fc, and sleep, we have been studying APP/PS1 transgenic (Tg) mice that develop Aβ plaques in a region-specific pattern similar to that in humans. We have also developed techniques to assess fc in mice using optical imaging (fcOIS). Our published and preliminary data suggest that endogenous synaptic activity and the sleep/wake cycle regulate levels of ISF Aβ and lactate acutely and Aβ accumulation chronically. Our preliminary data show that fc in young APP/PS1 Tg mice is normal; however, at 12 months of age, APP/PS1 mice have significant Aβ deposition and decreased fc as well as disrupted sleep. In this project, we will investigate the mechanisms linking glycolysis, hyperglycemia/ hyperinsulinemia, and sleep deprivation to changes in the default mode network, fc, behavior, and Aβ deposition. Hypothesis: Hyperglycemia, chronic hyperinsulinemia, and sleep deprivation all increase glycolysis and synaptic Aβ release, which chronically leads to increased Aβ deposition in the brain as well as synaptic dysfunction, accelerating the pathogenesis of AD. These ideas will be tested by combining microdialysis, fcOIS, behavior and neuropathology.

Public health relevance
Alzheimer's disease (AD) is the most common cause of dementia. Understanding how systemic changes in glucose, insulin and sleep affect energy metabolism in the brain, A¿ behavior, and functional connectivity, particularly within brain regions susceptible to developing Aβ pathology such as within the default mode network, will provide key insights into the relationship between brain energy metabolism, diabetes, and AD.